Mapping Transport Pathways through Nuclear Pores using 3D Super-Resolution Microscopy

PROJECT SUMMARY
Nuclear pore complexes (NPCs) mediate the bi-directional transport of proteins, RNAs and ribonucleoprotein
complexes across the double-membrane nuclear envelope of eukaryotic cells. Consequently, NPCs are
essential for the ability of many biosynthetic, signaling and gene regulatory processes to maintain cellular health
and viability. Protein mis-localization due to recognition defects or altered NPC structure and function is linked
to diseases as diverse as primary biliary cirrhosis, amyotrophic lateral sclerosis (ALS), leukemias and cancers,
and Alzheimer's and Huntington's diseases. While the protein components of the NPC and many soluble nuclear
transport factors have been identified and extensively studied, the mechanism(s) by which bi-directional transport
occurs without clogging the pore remains unknown. The NPC has an octagonally symmetric approximately
cylindrical structure with an hourglass-shaped central pore that has an internal minimal diameter of ~50-60 nm
in humans. Occluding this pore and decorating its exits is a network of > 200 mobile intrinsically disordered
polypeptides with thousands of phenylalanine-glycine (FG) repeat motifs that provide binding sites for the nuclear
transport receptors (NTRs) that carry cargos through the NPC. At steady-state, up to ~100 NTRs are
asymmetrically distributed throughout this FG-network. The heterogeneous and dynamic NTR/FG-network
establishes a permeability barrier while simultaneously providing pathways for the translocation of import and
export complexes of a wide range of sizes, affinities and surface properties. Multiple preferred paths through
the central pore exist. However, the overlap, selectivity, and geometric and functional properties of these
translocation conduits are largely unexplored due to the historical absence of technological tools to dissect these
pathways with the necessary spatial and temporal resolution. To address this deficiency, a multi-color three-
dimensional (3D) super-resolution fluorescence microscopy approach was developed in the last grant period
that is capable of determining the position and orientation of individual functional NPCs combined with single
particle trajectories of transiting cargo. This approach will be used to determine the structural and functional
properties of multiple translocation conduits and the FG-network barrier. The Specific Aims are: 1) to determine
the number and nature of protein translocation conduits; and 2) to determine the FG-polypeptide and NTR
distributions within the FG-network. Aim 1 seeks to explore the possibility of at least three distinct translocation
conduits, whether some of these consist of 8 distinct channels, and whether any are dedicated to either import
or export. Aim 2 seeks to determine how the physical arrangement and properties of components of the FG-
network are linked to promoting the identified translocation conduits. This work will directly address whether
preferred routes through the permeability barrier provide a means to avoid the competition and clogging expected
for two-way traffic through the same channel. In addition, improved super-resolution microscopy technologies
and algorithms are expected to comprise a necessary toolkit for the field as well as to have broad applicability.

Public health relevance
PROJECT NARRATIVE Nuclear pore complexes (NPCs) mediate the extensive trafficking of proteins and RNAs between the cytoplasm and the nucleus of eukaryotic cells and thereby act as a central control point in numerous cellular processes. The proposed work will identify the pathways utilized by protein cargos as they migrate through the NPC's permeability barrier. This work is important for understanding how nucleocytoplasmic partitioning in cells and tissues is generated and maintained as well as for establishing a sound foundation upon which to develop treatments for a wide range of human diseases.